Core B: Data Management

Summary, Data Mangement Core B
The Data Management Core B (hereafter, Core B) will be the nexus for all data management,
analysis, and harmonization activities in the Flavivirus and Alphavirus ReVAMPP (FLARE)
Center. The goal of Core B is to provide the expertise and resources necessary to collect,
evaluate, analyze, and share the data generated by the multidisciplinary research studies
performed by the five Projects and three Scientific Cores in the FLARE Center. As part of the
ReVAMPP Network, the Core B also will work closely with investigators in the FLARE Center
and the ReVAMPP Coordinating and Data Sharing Center (CDSC) to facilitate data harmonization
and sharing to enhance collaboration across the entire ReVAMPP network and with other external
stakeholders. Core B will support FLARE through two aims. The first aim will develop data
management systems and provide statistical analysis support for the FLARE Center. Core B will
establish and augment cloud-based data platforms (CIELO [Collaborative Informatics
Environment for Learning on Health Outcomes] and REDCap [Research Electronic Data
Capture]) for data capture, storage and sharing; develop a comprehensive quality-control system
to ensure high-quality data using prospective (quality checked in real time) and retrospective (data
cleaning) quality-control approaches; and support dissemination of results through statistical data
analysis and data visualization using SAS and R analytic platforms. The second aim will catalyze
data sharing and harmonization within the FLARE Center based on FAIR (Findable, Accessible,
Interoperable, and Reusable) data principles. Core B will enhance data findability using built-in
and customizable features of CIELO and REDCap that facilitate searching and metadata creation
and make data publicly available in both CIELO as well as other external data repositories (e.g.,
ImmPort, NCBI Genbank and SRA, PDB, EMDB, and EMPIAR). Core B will improve data
accessibility by leveraging Application Programming Interfaces (APIs) in both CIELO and
REDCap and ensure that data repositories have minimal restrictions for accessing publicly
available data (e.g., only requiring email address) and that all metadata is available on
repositories regardless of data availability. Finally, Core B will ensure data interoperability and
reusability by developing common data models and having metadata that describes usage
licenses, data provenance, and is consistent with community-accepted data standards. By
promoting and supporting the seamless exchange of high-quality data, within the FLARE Center,
across the ReVAMPP Network, and with external stakeholders and the public, Core B will play
an integral role in the development of novel immunogen designs and vaccine platforms and
monoclonal antibody therapies to be used for rapid deployment against emerging flaviviruses and
alphaviruses.